SCH: Robust and Equitable Clinical Decision Support in Glaucoma Detection and Progression Prediction

This project seeks to address the pressing issue of vision morbidity and vision impairment caused by
glaucoma. Glaucoma, a complex and multifactorial disease that develops over extended periods, presents
significant challenges in terms of early diagnosis and effective treatment within the existing healthcare
infrastructure. The research aims to harness the potential of artificial intelligence (AI) to not only enhance
our understanding of the disease but also to develop a clinical decision support tool that can significantly
improve glaucoma diagnosis and treatment.
The research seeks to innovate by tackling three specific challenges. The first challenge involves the
development of multi-modal approaches for robust glaucoma detection assessment and vision field loss
prediction. To accurately diagnose a patient, clinicians collect many types of data from several patient
visits. This research recognizes the critical importance of leveraging multiple sources of data to improve the
robustness and performance of glaucoma detection models. By integrating various data types, including
various retinal imaging and vision field measurement data, across different points in time, the proposed
clinical decision support tool is expected to provide a more comprehensive and accurate analysis of the
disease, leading to better treatment outcomes. The second challenge is how to promote trust and improve
adoption of AI-based decision support by clinicians and patients. The human-AI interface should provide
information about the performance and limitations of the model predictions to enable users to make safe
and effective decisions. Recent work has shown that uncertainty quantification can be effective in fostering
trust in AI systems. However, these methods need to be extended to be integrated with our proposed multi-
modal prediction pipeline to ensure robustness across multiple modalities with varying levels of reliability
and correlation structures. The third challenge focuses on mitigating bias and improving fairness in
glaucoma detection. By incorporating multi-modal information, the research aims to address these biases
and improve fairness in glaucoma diagnosis.

Public health relevance
This research will contribute to the development of a clinical decision support tool for glaucoma that enhances diagnostic accuracy and informs timely intervention. By integrating multiple sources of clinical data and validating the approach across real-world datasets, this project aims to support scalable and broadly applicable improvements in vision care, ultimately contributing to reduced rates of undiagnosed and undertreated glaucoma.